A Clinician-Facilitated Intervention to Integrate a Mobile Health App in Mental Health Care to Improve the Social Support of Veterans with PTSD

Background: Veterans with PTSD often have substantial interpersonal problems and low perceived social
support from family, partners, and peers. Interpersonal problems result in poor social reintegration and
functioning, which is associated with greater suicidal ideation and behavior. There is a critical need to provide
accessible treatments to Veterans with PTSD to reduce their social isolation by increasing their social support.
We created ACTsocial, a mobile app that provides Veterans with PTSD with motivational enhancement,
psychoeducation, and skills to improve their social support, thereby reducing their social isolation. We propose
to assess implementation constructs within the development process for an ACTsocial provider support guide
and then examine the acceptability, feasibility, and preliminary efficacy outcomes of integrating ACTsocial into
mental health care for Veterans with PTSD in a pilot trial.
Significance: Low social support is a key factor related to poor physical and mental health and increased
mortality risk for Veterans with PTSD, including from suicide. An approach with great potential to increase
social connectedness for Veterans with PTSD involves digital treatments, like ACTsocial. Adding support from
providers, including licensed and unlicensed providers, such as contact and monitoring, can increase use of
digital interventions like ACTsocial. This project will provide critical information on how to best integrate a
provider-supported ACTsocial app in mental health care.
Innovation & Impact: This study is innovative in several respects: 1) ACTsocial applies a promising evidence-
based treatment approach to the problem of poor social functioning and increased risk of suicide among
Veterans with PTSD; 2) ACTsocial will fill a substantial gap in accessible services that tackles social isolation
due to PTSD; and 3) there is an important need to understand how to best implement the ACTsocial app in
mental health care to increase Veteran engagement and provider support with the ACTsocial app.
Specific Aims: The primary objectives of the proposed project are to:
Aim 1. Develop a provider support guide for the integration of the ACTsocial app in mental health settings by
completing interviews with mental health providers (n=12), including psychologists and social workers (n=6)
and peer support specialists (n=6), as well as Veterans (n=12) guided by the Consolidated Framework for
Implementation Research framework to determine existing barriers and facilitators to integrating the ACTsocial
app into mental health care.
Aim 2. Examine the feasibility, acceptability, and preliminary efficacy outcomes of ACTsocial integrated into
mental health care among Veterans with PTSD (n=20) and mental health providers (n=4) in a pilot open trial
using both qualitative and quantitative methods.
Aim 3: Prepare a final version of the ACTsocial provider support guide and app for a future Hybrid Type 2
Effectiveness-Implementation trial.
Methodology: For Aim 1, we will develop the content for ACTsocial provider support guide using interview
data from mental health providers (psychologists, social workers, peer specialists) and Veterans. For Aim 2,
we will conduct a pilot trial of ACTsocial to gain information on acceptability and feasibility of integrating the
ACTsocial app in mental health care, and preliminary efficacy outcomes of the ACTsocial app using a mixed
methods approach. For Aim 3, we will use feasibility, acceptability, and efficacy data from the pilot trial to
make final revisions to the ACTsocial provider support guide and ACTsocial app.
Next Steps/Implementation: This pilot study will inform a future Hybrid Trial Type 2 Effectiveness-
Implementation trial to study the ACTsocial app integrated into mental health care. This research will lead to
future implementation and dissemination strategies to accelerate the benefits of ACTsocial to patient care.

Public health relevance
Veterans with PTSD often have impaired social relationships and poor social support. Increased social isolation among Veterans with PTSD places them at higher risk for poor physical health, poor clinical outcomes, increased mortality risk, and increased suicidal ideation and behavior. The ACTsocial app will provide a promising and accessible treatment approach that focuses specifically on the interpersonal challenges of these Veterans and fills a substantial gap in the need for treatments designed to improve the social functioning of Veterans with PTSD. The proposed study will evaluate important data on the feasibility, acceptability, and preliminary efficacy of integrating the ACTsocial app into mental health care settings. If study findings are positive, the proposed study will provide a critically-needed treatment resource and intervention approach for Veterans with PTSD that could be used concurrently with other mental health care to improve their social support and well-being.